Developmental Origins of Aggressive and Impulsive Behavior

Project Summary. Septal-hypothalamic neuronal activity centrally mediates aggressive behavior, while the
monoamine neurotransmitters dopamine and serotonin play strong and mostly opposing modulatory roles.
However, related circuit mechanisms and ontogeny are largely unknown. Making progress towards circuit
mechanism, we found in mice that dopamine input from the ventral tegmental area to the lateral septum is
sufficient for promoting aggression and necessary for establishing baseline aggression. Within the lateral
septum, dopamine acts on D2 receptors to inhibit GABA neurons that project to the hypothalamus. These
findings effectively link the clinically pertinent hyper-dopamine model of aggression with the classic septal-
hypothalamic aggression axis. Making progress towards ontogeny, we identified a sensitive developmental
window during adolescence where dopamine transporter blockade permanently increases adult aggression,
impulsivity, and behavioral stimulant response, and in parallel leads to a hyperactive dopamine system.
Conversely, periadolescent serotonin transporter blockade reduces aggression and behavioral stimulant
response in adulthood, and in parallel leads to a hypoactive dopamine system. Here we will continue this line of
research and study the overarching hypothesis that developmental DA and 5-HT signaling tunes DA input
into the LS and NAc to impact aggression-related behaviors in adulthood. In Aim 1, we investigate the
causal role of dopamine input into the nucleus accumbens in aggression-related behavior. Aggression is
behaviorally classified into reactive aggression which occurs impulsively in response to perceived external threat
and proactive aggression that is premeditated and directly motivated by a drive for appetitive reward. We
hypothesize that nucleus accumbens input contributes to the appetitive value in proactive aggression. In Aim 2,
we test the hypothesis that D2 receptors of the lateral septum contribute to sexual dimorphic differences in
aggressive behavior. We already found D2 receptors mediate dopamine-promoted aggression in male mice as
well as sexual dimorphism for D2 receptor expression. Furthermore, dopamine input into the lateral septum is
not sufficient to trigger aggression in females. In Aim 3, we investigate the causal role of serotonin input into the
lateral septum and nucleus accumbens in aggression-related behavior. Finally, in Aim 4, we investigate if
permanently altered DAergic input into the LS and NAc drives the aggression phenotypes after dopamine and
serotonin transporter blockade during development, by monitoring pathway-specific dopaminergic activity during
behavior, paired with optogenetic rescue experiments. By mapping circuits to behavior in the context of sensitive
developmental period interference, we will advance our understanding of normal as well as disrupted brain
development and function. Such information will impact the understanding of human risk factors for maladaptive
aggression and dopamine dysfunction. With the novel mechanistic and translational insight, we seek to inform
clinical and epidemiological studies and improve diagnosis, prevention and treatment strategies for in psychiatry.

Public health relevance
Project Narrative Most neuropsychiatric disorders have developmental origins, but knowledge about early risk factors, ontogeny, and mechanism remains scarce. We have identified a sensitive developmental period around adolescence, during which dopamine and serotonin modulate brain development to permanently and bi-directionally alter aggressive behavior and response to psychostimulants. Here we propose to study the underlying circuit-based mechanism, to ultimately improve diagnosis, prevention, and treatment strategies in psychiatric.